CORE--PREVENTION AND CONTROL

The Prevention & Control Research Core has been developed with Prevention & Control and Clinical Researchers of the DRTC to provide a range of consultation and direct services to support behavioral, patient centered/clinical, educational, and prevention research. Seven core services are: (1) assistance in recruitment of clinical and non-patient samples and recruitment of research settings for community oriented research; (2) assistance regarding clinical aspects of diabetes and assessment of clinical status and diabetes risk; (3) assistance regarding epidemiological aspects of research and analyses and accessing administrative databases; (4) assistance in planning, developing and evaluating health education interventions, including addressing cultural and psychological factors, diet and nutrition; (5) measuring psychological factors and quality of life among those with diabetes; (6) data gathering, administration of population-based and clinicbased surveys, and data management; and (7) statistical analysis of data, including biostatistical consultation and analysis using geographic information systems. Because the core is newly developed following NIDDK's changed DRTC guidelines, plans are in place to monitor the use and utility of the varied core services, eliminate underutilized services, add promising services, and reallocate funds accordingly. Not including research support for projects not using the Prevention & Control Core, users include six investigators with independent NIDDK funding (Brownson, Klein, Lustman, Racette, Sinacore, White), five investigators with other NIH funding for diabetes-related research (Haire-Joshu, Holloszy, Mueller, Newcomer, Wilfley), three investigators with non-NIH, externally funded diabetes-related projects (Fisher, McGill, Polonsky), and five investigators with prior or current Pilot & Feasibility funding and/or diabetesrelated projects planned (Auslander, Hams, Hershey, Perkinson, Schootman).